Task A80: Advanced Small Animal Models for the Testing of Candidate Interventions against Mycobacteria

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.